Endothelial Rap1 restricts inflammation in the retina

PROJECT SUMMARY
Endothelial-leukocyte interactions are pivotal in Diabetic Retinopathy (DR), a major cause of global vision
loss. Proinflammatory factors like tumor necrosis factor alpha (TNF-α) drive hyperactivity in retinal endothelial
cells (RECs), leading to inflammation, increased leukocyte adhesion, and ultimately pathological
neovascularization. Understanding REC-leukocyte dynamics is crucial for early intervention. Vascular
Endothelial Growth Factor (VEGF), is a key player in DR influencing REC behavior and serving as therapy target.
However, it also maintains cellular homeostasis during inflammation. Deciphering retinal mechanisms balancing
proinflammatory and homeostatic responses is crucial for optimizing DR treatments. REC responsiveness
hinges on lipid rafts and specialized plasma membranes domains, caveolae. Understanding how homeostatic
and proinflammatory signals are balanced in these structures remains a critical research goal.
Our published data indicate that endothelial Rap1B (Ras association proximate 1B), a signaling molecule
in ECs, enhances nitric oxide release and limits proinflammatory signaling in ECs, and is essential for VEGFR2
activation and signaling. In the retina, Rap1B is critical for physiological retinal development yet endothelial
Rap1B knockout (KO) reduces VEGF-driven pathological hyper-permeability in streptozotocin-induced diabetes.
Our preliminary data indicate Rap1B localizes to cholesterol-rich lipid rafts to orchestrate VEGFR2 signaling.
Restoring cholesterol in Rap1B-deficient ECs reinstates deficient VEGF-triggered NO signaling. These results
led to our hypothesis: Rap1B governs the equilibrium between homeostasis and inflammation in RECs during
DR progression by modulating the composition and organization of lipid rafts. To investigate the regulatory role
of Rap1B in RECs in progression of DR, we propose to: (Aim1) Assess Rap1B's role in regulating VEGF-
VEGFR2 lipid rafts. Employ a two-tier genetic strategy (Rap1B KO and functional mutants in RECs),
complemented by advanced microscopy, omics, and signal transduction analyses, to elucidate Rap1B's
influence on VEGFR2 lipid raft structure, composition, and signaling. (Aim 2) Examine how Rap1B controls the
balance between VEGFR2 and TNFR1 signaling. Apply methods from Aim 1 to discern Rap1B's effect on TNFR1
lipid raft organization, composition, and redox signaling. Evaluate Rap1B's role in ROS and NO-mediated
leukostasis and explore hyperglycemia's impact on Rap1B signaling. (Aim 3) Establish the impact of EC Rap1B
on EC-leukocyte dynamics in vivo. Utilize advanced microscopy and transcriptomics to determine Rap1B's role
in Rap1B on leukocyte-dependent vascular obliteration, permeability and leukostasis in DR and using a
retinopathy of prematurity model, on neovascularization. These studies will define molecular roles of Rap1 in
RECs and provide critical insights into the mechanisms controlling the balance of REC responses to VEGF and
proinflammatory stimuli in DR, information critical to improve therapeutic strategies for retinal ischemic diseases.

Public health relevance
PROJECT NARRATIVE Diabetic retinopathy, a prevalent microvascular complication, is the leading cause of vision loss worldwide. This project seeks to understand the mechanisms through which endothelial cells control interactions with leukocytes, and, thereby, the outcomes of diabetic retinopathy. This information is critical to improve therapeutic strategies for retinal diseases and to prevent blindness.